Essential Fatty Acid Deficiency as a modifiable determinant of cognitive dysfunction among 6-18-year-old Ugandan children of varying perinatal HIV status

PROJECT SUMMARY/ABSTRACT
More than 1 in 3 children from low middle-income countries are at risk of neurocognitive disorder (ND)
and/or significant scholastic problems due to high burden of infectious morbidity and malnutrition which
contributes to immune dysfunction and disruption of normal host-microbe interactions in the gut (i.e., intestinal
dysbiosis). While all children are at risk, the risk of neurocognitive dysfunction for perinatally HIV-infected
(PHIV) and HIV-exposed uninfected (HEU) children is amplified by current and/or early life antiretroviral
therapy (ART). ART for HIV-infected pregnant women effectively reduces the likelihood of mother-to-child
transmission of HIV. This exposure, however, increases the likelihood of a range of risk factors for adverse
neurodevelopmental outcomes such as low birth weight, metabolic problems, and neurotoxicity among children
whose mothers received ART in pregnancy. Further, persons living with HIV and HEU children have different
intestinal microbiomes compared to community controls. The extent to which interactions between nutritional
deficiency, intestinal dysbiosis, and current ART or in utero/peripartum ART history among HIV-affected
children creates a negative feedback loop that worsens ND, related outcomes relative to HIV unexposed
uninfected (HUU) children is unknown. This gap in current understanding is addressed in this project.
As part of completed and ongoing research, our team has established and maintained a large cohort of
school-aged and adolescent (ages 6 to 18 years) PHIV (n=255), HEU (n=254) and HUU (n=257) children from
Uganda. Most (49.7%) HIV exposed children in our existing cohort did not receive any peripartum ART to
prevent HIV mother-to-child-transmission. The vast majority of those that received any peripartum intervention
were exposed to sub-optimal IPA (34.8%) and a relative minority (15%) were exposed to combination ART
through their mothers in the in utero/peripartum period. The parent project allows this team to follow the
already established cohort for three more years, conduct annual assessment of cognition and repeated
measures of nutrition, intestinal dysbiosis, and immune dysfunction. The data will be integrated with already
available information to implement definitive analyses of relationships between change in neurocognitive
outcomes over 36 months follow-up and perinatal HIV status, early ART status, and Essential Fatty Acid
Deficiency.
Overall Impact: By implementing this project, we will identify children who are at risk of worse
developmental outcomes so that the available supportive care interventions can be directed to those in
greatest need. Second, the predictors of neurocognitive risk evaluated are potentially modifiable, opening
another avenue to intervene to ensure that all children are developmentally thriving in the long-term.

Public health relevance
PROJECT NARRATIVE/RELEVANCE This project leverages existing infrastructure established by the parent study to implement analyses of the importance of Essential Fatty Acid Deficiency (EFAD), perinatal HIV status, and in utero/peripartum antiretroviral therapy (IPA) exposure for cognitive outcomes (executive functioning and scholastic outcomes) in early and late childhood. Objective reliable information on IPA exposure type and perinatal HIV status has already been obtained by using medical records to link children and their birth mothers during pregnancy and infancy in the parent study. The parent study provides a rich context for the training of Ms. Vanessa Cardino in her quest to become a research professor in global nutrition and applied neuroscience.